Developing AI-measures of Pedestrian Environment Features for Physical Activity and Cancer Prevention in Rural Communities

7. Project Summary/Abstract
Residents of rural areas often exhibit lower rates of physical activity (PA), correlating to elevated cancer
incidence and mortality rates compared to urban dwellers. The lack of PA resources significantly contributes to
the lower rates of PA observed among racially and ethnically diverse and lower-income rural populations. A
major obstacle to addressing urban-rural PA and cancer disparities is an insufficient understanding of the
neighborhood environment—specifically, the pedestrian environment features that inhibit or promote PA—
which can be cost-effectively modified. Existing, publicly available pedestrian environment measures assess
macroscale walkability features (e.g., land use mix, street intersection density) that are costly and infeasible to
improve in rural areas. While smaller-scale research has identified more affordable, microscale Pedestrian
Environment Features (PEFs) (e.g., sidewalks, crosswalks, lighting), person-led, microscale audits of PEFs
show limited feasibility across expansive rural geographies. Machine learning algorithms have been developed
using data from urban and suburban areas to audit microscale PEFs, but these can introduce bias when
scaled up for use across expansive rural areas to study their relationship with PA. Addressing urban-rural
cancer disparities necessitates assessing the association between microscale PEFs and PA in both urban and
rural areas of the US. Therefore, we propose three specific aims: 1) further validate existing machine learning
algorithms to assess 9 microscale PEFs (sidewalks, sidewalk buffers, curb ramps, zebra and line crosswalks,
walk signals, bike symbols, benches, and lighting) for rural areas, 2) test the relationship between rural
microscale PEFs and middle to older age adult PA, and 3) identify disparities in microscale PEFs by income
levels, racial and ethnic composition, & geographic location across the US. We will retrain and leverage
existing deep learning classifiers developed as part of preliminary work funded by the National Cancer Institute
to assess urban and suburban microscale PEFs, to create classifiers that generalize and perform well in rural
areas. We will validate these microscale PEF classifiers with human virtual audits and examine their
relationship with PA among middle and older age adults, given this age group is at high risk for physical
inactivity. We hypothesize that greater rural PEFs will be associated with greater minutes per week of total PA
and walking, as measured by the International Physical Activity Questionnaire, after adjusting for covariates.
Finally, we will explore income, racial, ethnic, and regional disparities in rural microscale PEFs across the US
where policy or environmental intervention may be necessary. This project aims to validate a new scalable tool
for identifying rural PEFs and uncovering potential environmental and health-related disparities in diverse rural
locales across the US. Results will inform larger-scale research that uses AI-measured PEF assessments to
address physical inactivity and cancer-related health disparities. In turn, existing cancer prevention and PA
promotion initiatives can intervene on lower-cost and modifiable neighborhood environment features.

Public health relevance
8. Project Narrative This research is critical for understanding the link between rural pedestrian resources and modifiable cancer risk factors such as physical activity. Existing research has ostensibly focused on large-scale walkability features that are infeasible to improve in rural areas, but substantial barriers exist to measuring more changeable micro-scale pedestrian environment features (e.g. sidewalks, lighting) across rural geographies. This project will overcome feasibility issues in conducting in-person audits of micro-scale environmental features in under-resourced and expansive rural communities by leveraging artificial intelligence and assessing the understudied link between disparate micro-scale pedestrian environments and physical activity among middle to older-aged adults across the United States.